KETOACID THERAPY OF RENAL FAILURE

The goal of this project is to slow or stop progression of chronic renal failure by monitoring patients' symptoms and prescribing nutritional therapy and supplementation.